Development of Monoclonal Antibodies to Types C, D, F and G Botulinum Toxins

This Interagency Agreement provides for the production and characterization of Clostridium botulinum toxins and for the use of these toxins as immunogens to derive monoclonal antibodies.